LA RED NETWORK INFORMATICS TECHNOLOGY SUPPORT TASK ORDER

This funding supports information technology(IT) consultation and support for the La Red Network in order to maximize La Red clinical research productivity through the use of applicable IT systems; hardware, software, training and maintenance across the ten sites in La Red.